Disrupting Apicoplast DNA Replication in Plasmodium: Identifying Key Proteases for Antimalarial Therapy

Malaria remains a global health crisis, causing over 600,000 deaths annually, with most
fatalities occurring in children under five. Plasmodium falciparum, the causative agent of
malaria, relies on the apicoplast for key biosynthetic functions like isoprenoid production. The
apicoplast is indispensable for parasite survival, making it a prime target for antimalarial
therapies. Prex, a polyprotein containing DNA primase, helicase, and polymerase domains, is
crucial for replicating the apicoplast genome. However, the proteases responsible for
processing Prex into its functional subunits remain unidentified, representing a critical gap in our
understanding of apicoplast DNA replication. Preliminary studies have identified three
candidate proteases that potentially interact with Prex. This proposal will now focus on
characterizing these proteases to better understand their role in apicoplast function and
biogenesis. Aim 1 will confirm the localization of these proteases within the apicoplast, assess
their importance for parasite growth and Prex maturation, and determine their complete set of
interacting proteins. Aim 2 will characterize the biochemical properties of the proteases, using
targeted and unbiased approaches to identify their substrates and map cleavage sites. This
research will provide essential insights into proteolytic processes within the apicoplast,
regardless of whether the candidate proteases directly process Prex. The findings will inform
future high-throughput screens for small-molecule inhibitors targeting these proteases and
support the identification of new therapeutic targets for novel antimalarial therapies.

Public health relevance
Project Narrative Malaria continues to be a major cause of death, especially among children under five, with the growing spread of drug-resistant Plasmodium falciparum posing a significant challenge to global control efforts. This project aims to identify and characterize proteases essential for apicoplast DNA replication, a vital process for parasite survival. By targeting these proteases, we may uncover novel drug targets, leading to new therapies that combat drug-resistant malaria and reduce the global burden of this disease.